Characterizing the Molecular Basis of Supergene Mimicry in Butterflies

Characterizing the Molecular Basis of Supergene Mimicry in Butterflies
Project Summary
Why is life on Earth so diverse? How do these diverse forms arise, both over evolutionary time and during
development? What are the functional molecular and genetic changes that underlie the fantastic organismal
diversity we see in the natural world? My research focuses on these big questions related to the origin of
biodiversity, but I do so through the lens of mechanism. Butterflies, and butterfly wing patterns in particular,
offer an excellent system to unlock the functional molecular and genetic mechanisms responsible for
organismal evolution because of their natural diversity, a long history of research that puts this diversity in a
much-needed ecological context, and our success at establishing genomic and genome editing tools for
butterflies. My research team and I study diversity using multiple approaches, including molecular and
population genetics, genomics, developmental biology techniques, functional genomics, genome editing,
neurobiology, behavioral experiments, and computation. The ultimate goal of this work is very fundamental: I
strive to characterize the functional mechanisms responsible for historical evolutionary processes while also
uncovering basic principles of biological patterning, development, and behavior. Much of our research is
focused on the phenomenon of sex-limited polymorphism, which is widespread in animals but is not well
understood in any organism. “Supergene” mimicry in the swallowtail butterfly Papilio polytes stands out as a
particularly striking example of sex-limited polymorphism and one that is amenable to functional
characterization. While much theoretical work has explored the evolutionary dynamics of supergene mimicry,
we are just beginning to unpack its molecular and developmental basis. Previously we determined that the
gene doublesex controls the mimicry switch in P. polytes and we have studied the origin and evolution of
mimicry, behavioral aspects of mimicry, natural selection in nature, and we have developed tools and methods
for CRISPR and multiple functional genomics assays. Using these tools, we have begun to characterize the
cis-regulatory architecture of doublesex, as well as the gene regulatory networks that are modified by
doublesex to produce novel mimetic wing patterns. Over the next five years, we will investigate the functional
basis of supergene mimicry in P. polytes by integrating genomics, functional genetics, molecular and
developmental biology, providing the single most comprehensive investigation of its kind. Furthermore, we will
greatly expand the scope of our analyses by branching out on the butterfly phylogeny to functionally
characterize parallel evolution of supergene mimicry in other butterflies. Our work will greatly expand the
known role of the sexual differentiation pathway and generate general insights into fundamental evolutionary
genetic processes of convergence, cis-regulatory evolution, and gene co-option.

Public health relevance
Characterizing the Molecular Basis of Supergene Mimicry in Butterflies Project Narrative Humans have pronounced sexual dimorphism with a number of diseases and traits exhibiting sex-limited polymorphism. My proposal is aimed at characterizing the genetic and developmental basis of sex-limited polymorphism in a mimetic butterfly. This work will greatly expand the known role of the sex determination pathway, and generate general insights into molecular and cellular causes of sexual differentiation, dimorphism, and sex-limited polymorphism.